Pathways and interactions accounting for the oligomerization of amyloid peptides

The aggregation of amyloid peptides into soluble oligomers and fibrils is a hallmark of Alzheimer’s
disease. The interaction of these aggregates with the cell membrane accounts for an important
mechanism of toxicity wherein oligomers can form pores in lipid membranes and amyloid fibrils can
induce lipid loss. As monomers, i.e., individual peptides, have been found to be mostly nontoxic, the
development of strategies to inhibit aggregation has the potential to translate into the development of
new preventive treatments for Alzheimer’s disease. These efforts require, however, a deep
understanding of the interactions accounting for amyloid aggregation.
Previously, the aggregation of peptides in bulk solution, i.e., primary nucleation, was assumed to be
the main mechanism accounting for the formation of oligomers. More recently, this assumption was
reassessed by careful kinetic experiments, which can only be explained quantitatively assuming that
most oligomers form on the surface of existing fibrils in a process known as secondary nucleation.
Currently, there is a critical lack of understanding of the molecular interactions and pathways accounting
for secondary nucleation. This remains a serious impediment for the rational design of drugs that can
inhibit oligomerization on the fibril surface. This proposal uses innovative all-atom molecular dynamics
simulations complemented with biophysical and biochemical experiments to fill this knowledge gap. It
takes advantage of improvements in the development of force fields as well as in the enhanced
performance of today’s supercomputers that can now track the position of many atoms (~250,000
atoms) for a long-time (>10 μs). Moreover, this project provides opportunities for undergraduate
students to participate in all aspects of this research including setting up, running, and analyzing
simulations in different supercomputer clusters.
All-atom simulations will be used in aim 1 of this project to determine how the peptide sequence affects
pathways and interactions accounting for oligomerization in bulk solution. Simulations in aims 2 and 3
will be performed in large boxes containing a seeded fibril. In aim 2, a systematic study will be carried
out to shed light into effects of the fibril surface and the peptide sequence on fibril elongation.
Oligomerization pathways at the fibril surface, i.e., secondary nucleation, will be studied in aim 3. A
comparative study of oligomerization pathways in primary and secondary nucleation will be performed
to determine the interactions enabling the fibril surface to catalyze the aggregation process.

Public health relevance
The proposed research will provide insights into the molecular interactions accounting for the aggregation of amyloid peptides and their toxicity in neurodegenerative diseases. This is critical for the rational design of drugs to treat and/or prevent diseases like Alzheimer’s and Parkinson’s.